South Carolina Department of Health-Laboratory Flexible Funding Model Application

SC-DPH Overall Summary
The South Carolina Department of Health (SC-DPH), Public Health Laboratory (PHL), serves as
the state public health laboratory working towards improving the quality of life for South
Carolinians by protecting and promoting the health of the public and environment. The PHL
Food Microbiology Laboratory has maintained the ability to test for foodborne pathogens and
food quality indicator organisms for over 45 years and in 2016 achieved ISO/IEC 17025
accreditation and has remained accredited since that time. During this cooperative agreement,
the Food Microbiology Laboratory will maintain ISO/IEC 17025 accreditation by remaining
compliant with requirements set forth by our accrediting body and by maintaining a quality
management system that addresses and conforms to all elements of ISO/IEC 17025 standards
by performing internal audits, management reviews, proficiency testing, and quality system
improvements. Through a partnership with the state Manufactured Food Retail Program
Standards (MFRPS) programs, and the state Animal Food Retail Product Program Standards
(AFRPS) program the Food Microbiology Laboratory will participate in the enhanced
surveillance with a total of 350 analyses for human food and animal food products. The
performance of whole genome sequencing on samples routinely collected and processed from
environmental sources will contribute to growing knowledge and understanding of microbial
ecology and diversity. The sharing of this data generated through routine surveillance activities
will allow the Food and Drug Administration access to our data for enforcement activities. The
fact that this data will be generated in an ISO/IEC 17025 accredited laboratory will streamline
analytical review and allow the FDA to rapidly respond and enforce regulatory compliance.
These projects will serve as a foundation to strengthen and improve the FDA’s efforts to prevent
foodborne illness and minimize exposures in order to build upon a nationally integrated
laboratory science system and equips partner laboratories with additional resources to increase
sample throughput capacity within the state.

Public health relevance
South Carolina Department of Health Narrative The overall purpose of this cooperative agreement is to enhance the capacity and capabilities of state human and animal food testing laboratories in support of an integrated food safety system. South Carolina will enhance and support a national level integrated system by expanding routine surveillance of human and animal food products and also contribute to a growing understanding of microbial ecology and diversity through whole genome sequencing of foodborne pathogens and environmental isolates. These projects will serve as a foundation to strengthen and improve the FDA’s efforts to prevent foodborne illness and minimize exposures in order to build upon a nationally integrated laboratory science system and equips partner laboratories with additional resources to increase sample throughput capacity within the state.